RNA Polymerase II as a Therapeutic Target in Acute Myeloid Leukemia (AML) with RAS Signaling Activation

PROJECT SUMMARY/ABSTRACT OF PARENT GRANT
Background: Fms-Like Tyrosine Kinase 3 (FLT3) is the most commonly mutated gene in acute
myeloid leukemia (AML) and mutations in FLT3 are associated with high relapse rates. FLT3
tyrosine kinase inhibitors (TKIs) are clinically active in FLT3-mutant AML but duration of
response is limited by the development of resistance. Mutations in NRAS and other activation
of the RAS pathway are major mechanisms of resistance to FLT3 inhibitors and other AML
targeted therapies. Rationale: We have identified suppression of the Mediator/RNA Pol II
pathway augments FLT3 TKI-induced apoptosis in the setting of RAS activation. The overall
goals of this project are: (1) to prioritize therapeutic targets in the Mediator/RNA Pol II pathway;
and (2) to determine the essential Mediator/RNA Pol II-dependent transcriptional targets
relevant to FLT3 TKI resistance. Methods: We will identify essential components of the RNA Pol
II pathway needed for TKI resistance in AML and evaluate the efficacy of existing RNA Pol II
pathway inhibitors in MAPK-activated AML cells. We will determine RNA Pol II-dependent
transcriptional changes induced by MAPK activation and FLT3 inhibition in pre-clinical models
and patient samples. We will functionally validate the essential downstream transcriptional
targets critical to RAS-mediated FLT3 TKI resistance in AML. Expected Results: These studies
will rigorously evaluate RNA Pol II as a novel treatment strategy in AML with aberrant
RAS/MAPK signaling. If successful, this strategy can be quickly translated to clinical trials in
AML and this general approach may also prove efficacious in other RAS-mutant cancers.

Public health relevance
PROJECT NARRATIVE OF PARENT GRANT This research focuses on acute myeloid leukemia (AML), which affects more than 10,000 Americans annually, the majority of who die of their disease within a short time. This research addresses the role of aberrant RAS signaling in relapsed/refractory AML and the efficacy of Mediator/RNA Pol II targeting as novel treatment strategy. The overall goal of this work is to establish new and effective strategies to treat relapsed/refractory AML.